Admin Core

Project Summary
Antimicrobial innovation has slowed to a crawl while an epidemic of antimicrobial-resistant infections surges,
threatening the public health. The overarching goal of the Wisconsin Antimicrobial Drug Discovery and
Development Center is to develop therapeutic countermeasures to tackle the antimicrobial resistance crisis.
Based upon our preliminary data, we hypothesize that natural product exploration of symbiotic environments
using complementary cutting-edge approaches will provide a new paradigm for discovery of novel
antimicrobials targeting drug resistant infections. The Center proposes innovative conceptual and technical
advances to overcome critical bottlenecks identified in traditional antimicrobial drug discovery platforms. The
success of this endeavor hinges upon the cohesive efforts from a diverse group of scientists and technical
resources. The Administrative Core will be directed by Andes and advised by an Internal and External Advisory
Board comprised of experts in infectious diseases, antimicrobial resistance, drug discovery and development,
natural products, and technology transfer and licensing. Additionally, it will include an administrator with
extensive experience in research and business administration, and prior oversight of NIH funded program
projects and centers. The overall goals of the administrative core are to provide leadership and the
organizational back bone for this proposal, promote collaboration between the Projects and Cores, and
coordinate its interaction with NIAID staff.
/Relevance/
There are no effective therapies for the emerging resistant pathogens that are becoming an increasing threat
to the public health. The goals of the Center are to provide new, broad spectrum antimicrobial agents through
a collaborative focus on high value natural product leads produced by under-explored sources of biological
diversity.

Public health relevance
Narrative: Bacterial and fungal pathogens for which there are no effective therapies (drug-resistant) are rapidly emerging. The proposed investigations will develop a new platform for discovery of the next generation of antimicrobial drugs. This new platform takes advantage of the evolutionary selection of highly relevant natural products from symbiotic relationships between animals and antibiotic producing bacterial. The Administrative Core will oversee all research studies, provide leadership and the organizational back bone for this proposal, and promote collaboration between the Projects and Cores. The Core is comprised of leaders in infectious diseases, antimicrobial resistance, drug discovery and development, and natural products.